Nanomicellar antiviral strategies for RSV infection

The major goal of this program is to further develop and translate recent discoveries in biology of
respiratory syncytial virus (RSV), an important pathogen that infects an estimated 64 million people
and causes ~200, 000 deaths globally every year. In the US, RSV causes >11,000 deaths of
elderly annually. There is no effective treatment or vaccine against RSV infection. Currently, only
high-risk infants receive antibody-based prophylaxis, which is expensive and moderately effective
in reducing hospitalization. Therefore, a broadly applicable, effective and inexpensive approach to
prevent or treat RSV-bronchiolitis or -pneumonia remains an urgent unmet need.
This proposal to develop and test a novel prophylaxis and/or therapy against RSV infection was
inspired by the following discoveries. i) A platform of phospholipid micellar nanoparticles (PMN)
was developed, which when given intranasally delivers payload predominantly to the lung. ii) A
decoy short heptad repeat (HR)2 peptide was identified, which effectively inhibits the RSV-cell
fusion. iii) Human mesenchymal cells were found to be highly susceptible to RSV. The latter aided
in establishing a novel 3D scaffold for anti-RSV drug screens, which consisted of creating a naked
mouse lung scaffold (nMLS) by decellularization followed by recellularization of the nMLS with
desired human cells, such as hMSCs and epithelial cells and then infecting the cells in scaffold
with RSV. iv) A robust immunocompromised mouse model was created by combining
cyclophosphamide treatment with infection by a highly mucogenic strain, RSV-L19F. These
developments have led to the hypothesis that a RSV-targeted PMN (RTPMN), combining HR2D
anti-fusion peptide, and plasmid encoded siRNAs against RSV-NS1 and/or RSV-P gene can
provide a safe, effective and inexpensive anti-RSV prophylaxis and/or therapy. Three specific aims
(SAs) will test these hypotheses.
In SA#1, multifunctional and smart RTPMNs will be synthesized with plasmids encoding
siRNAs for RSV-NS1and RSV-P genes in the core and anti-fusion HR2D peptides on the surface
and be characterized in vitro. In SA#2, RTPMNs will be examined for their biodistribution, pharm-tox
and PK/PD properties. SA#3 will examine the prophylactic and therapeutic potential of RTPMN-
HR2D-psiNS1-P against RSV infection in an in vitro 3D lung scaffold and in immunocompromised
mice to investigate the mechanism of action.
The results of these highly innovative multidisciplinary translational studies are expected to
increase the understanding of RSV pathology in humanized mouse lung model and in a model
using adult immunocompromised mice. A successful completion of preclinical formulation of anti-
RSV PMN-based prophylactics and therapeutics is expected to pave the way to IND-driven studies
and clinical trials.

Public health relevance
As an opportunistic human respiratory pathogen, RSV, is becoming more and more of a serious threat to immuno-compromised and aging veterans and is considered globally as a significant infection causing 64 million infections and ~200,000 deaths annually. The goal of this proposal is to investigate the potential of a novel nanotherapy approach which combines fusion blocking peptide with a replication inhibiting siRNAs, to target RSV infection. The safety and efficacy of this nanotherapy will be tested using relevant pre-clinical model systems. The knowledge obtained from these pre-clinical studies will be used to develop an investigational new drug against RSV infection in the future. !